Biostatistics Shared Resource

Biostatistics Shared Resource Summary
Proper and efficient statistical design and analysis is critical to the conduct of rigorous and reproducible
studies. The mission of the Biostatistics Shared Resource is to provide state-of-the-art services in the planning,
conduct, analysis, and reporting of cancer-related basic science studies, population science studies, and
clinical science studies—especially clinical trials. The mission is achieved through the following specific aims:
1) To support and collaborate with Masonic Cancer Center researchers on all activities, at all stages related to
the preparation of grant applications; 2) To support and collaborate with Masonic Cancer Center researchers
on the execution of all stages of funded research projects; 3) To support the design and data analyses of all
studies, whether funded externally, internally, partially funded by departments, or even unfunded; 4) To support
and implement quality assurance and data management plans for all collected data; and 5) To support and
participate in protocol design, monitoring, and reporting through collaboration with the Clinical Trials Office and
participation in the Cancer Protocol Review Committee and the Data Safety and Monitoring Committee.
The Biostatistics Shared Resource provides consultation and education to Cancer Center members and their
trainees in Basic, Population, and Clinical Sciences in preparing grant applications. It ensures that all
experimental designs, study monitoring, and data analyses take advantage of robust and efficient methods that
reflect best practices in biostatistics and supports the activities of the Clinical Trials Office. The Shared
Resource was used by 86 individuals in fiscal year 2022, 60 of whom were Cancer Center members.
The Biostatistics Shared Resource is led by Dr. Chap T. Le (Transplant and Cellular Therapy Program). It is
currently staffed by 8 faculty members, including Dr. Le (3 Full Professors, 2 Associate Professors, and 3
Assistant Professors) and 6 master’s-level research fellows and senior research fellows.
During the current funding cycle, we were able to expand the Biostatistics Shared Resource from 11 to 14
members; we have maintained stable leadership and can offer Cancer Center members well-organized and
well-coordinated support. The quality of our service benefits from specialization, with each member focusing on
a limited number of technical areas and research programs; continuing education, with master’s-level staff
encouraged to audit courses on new topics; and oversight of staff by senior statisticians who provide advice,
mentoring, and monitoring. Weekly meetings provide time to discuss technical issues in addition to operational
issues. Therefore, the Biostatistics Shared Resource makes significant contributions to the quality of research
in the Masonic Cancer Center.